Pathogenic T cells in discoid lupus erythematosus

PROJECT SUMMARY
Discoid lupus erythematosus (DLE) is a disfiguring autoimmune skin disease with a predilection for affecting
the head and neck that causes permanent scarring, hypopigmentation, and alopecia. DLE disproportionately
affects African American women, and it severely impairs quality of life. DLE may occur alone or in the setting of
systemic lupus erythematosus (SLE), and treatments for DLE are currently unsatisfactory. The DLE
inflammatory infiltrate is predominantly composed of T cells, which appear to promote tissue inflammation and
damage, but how they adapt to the skin environment and subsequently promote tissue injury is unknown. We
recently identified an inflammatory gene program induced by the transcription factor hypoxia inducible factor
(HIF) that is necessary for the survival and effector ability of pathogenic T cells in lupus-prone mice, with a
similar program upregulated in human SLE. Yet, how HIF1 promotes damage and what other tissue adaptation
and effector pathways are activated in skin-infiltrating T cells in DLE are not known. Based on my preliminary
studies, I hypothesize that HIF1 regulates pathogenic T cell survival and effector function in DLE skin, causing
inflammation and damage that may be mediated in part by enhanced cytotoxicity. This HIF1-regulated effector
program also suggests a paradigm of pathogenic adaptation in tissue-infiltrating T cells with the potential to
drive tissue damage. To test my hypothesis, I will determine the mechanism of HIF1 blockade in alleviating
skin disease in a murine lupus model. I will also study human DLE skin and blood samples using single cell
RNA sequencing to probe the developmental trajectory, phenotypic, and functional profile of T cells in human
DLE. Finally, I will use imaging techniques to examine the role of cytotoxicity in tissue damage in human DLE,
with parallel studies in mouse tissue. My studies will not only elucidate the role of HIF1 and cytotoxicity in DLE,
but will also yield the first detailed characterization of infiltrating and circulating T cells in human DLE, paving
the way for future studies to develop and evaluate novel therapeutics for this devastating disease. My proposal
will also support a period of career development during which I will receive additional training in basic and
translational immunology in the laboratory of Dr. Joseph Craft, a leader in the fields of lupus research and T
cell biology. Dr. Craft's laboratory in the Yale Department of Immunobiology provides a highly collaborative and
supportive research environment. To further support my training, I have assembled an advisory committee with
experts in transcriptomic analyses, translational dermatology, cutaneous T cell biology, and autoimmune skin
disease. My research studies and directed additional career development activities focused on computational
approaches, human translational research, and biostatistics in clinical investigation will allow me to
successfully achieve research independence as a physician scientist and open my own laboratory so that I can
use basic and translational immunologic approaches to study cutaneous autoimmune diseases including DLE.

Public health relevance
PROJECT NARRATIVE Discoid lupus erythematosus is a chronic disfiguring autoimmune skin disease characterized by an immune cell infiltrate predominantly composed of T lymphocytes, which appear to promote tissue inflammation and damage, but how they do so is not well understood. I will perform translational immunologic research on human skin and blood samples with parallel studies in a mouse model to delineate the roles of key survival, inflammatory, cytotoxic, and other effector pathways in potentially pathogenic T lymphocytes, and to probe how they are regulated. These efforts will advance our understanding of discoid lupus erythematosus and help identify targeted strategies for treating this disease.